Metabolomics Laboratory

The Metabolomics Laboratory Shared Resource (MBX) provides rapid and routine metabolomics services as
well as custom method development and data analysis to Perlmutter Cancer Center (PCC) members and their
collaborators. MBX is critical to the research of the four Research Programs, as metabolomics analyses play an
increasingly important role in basic and translational research. MBX is directed by Drew Jones, PhD, Assistant
Professor of Biochemistry and Molecular Pharmacology. He has 16 years of experience with mass spectrometry
(MS) and metabolomics informatics and has led MBX since its inception in 2017. MBX was founded to serve the
growing need for metabolomics analyses in PCC research and was a Developing Core in the 2018 CCSG. Owing
to its high usage, productivity, and strong member satisfaction, it is presented as full shared resource (SR) in the
current application. The laboratory has ~1,500-sq ft of space for instruments, benches, and sample processing,
and office space for 5 expertly trained staff members. Like other PCC SR, MBX, is overseen by the Division for
Advanced Research Technologies (DART), has an Advisory Board composed of PCC members and other NYU
faculty, and is subject to yearly surveys to ensure alignment with PCC member needs. MBX offers a range of
MS-based metabolomics platforms including standard panels, global & untargeted metabolomics, lipidomics,
and mass spectrometry imaging (MSI), but also develops and validates custom targeted methods. MBX also
offers several user-accessible instruments for metabolic phenotyping and metabolite purification, with support
and training by MBX staff. MBX participates at all levels of projects including experimental design, sample
harvesting, metabolite extraction, data acquisition, quality control, data analysis, and generation of publication-
quality figures. For all projects, MBX delivers a comprehensive statistical data package using informatics tools
and pipelines developed by MBX bioinformaticians. MBX staff present these results to PCC members in an exit
consultation, further strengthening their scientific relationship with PCC members. MBX also offers training and
mentoring of graduate students and post-doctoral researchers who are interested in learning metabolomics
informatics theory and application, and Jones has served on nine thesis committees of NYU-affiliated students
to-date. MBX is continuously growing and updating its instrument fleet to fit the needs of all PCC members. The
Specific Aims of MBX are: 1) To provide a wide range of expert, state-of-the-art metabolomics services,
including global/untargeted metabolomics, custom targeted/quantitative methods development, and
bioinformatic analysis of complex datasets, including multi-omic analyses and large-multi batch projects, 2) To
facilitate high-quality, reproducible data processing and storage of metabolomics data for PCC Research
Programs, and develop and publish novel informatic approaches to metabolomics data processing, and 3) To
pursue the evaluation and development of novel technology platforms in the metabolomics field and expand the
suite of capabilities and instrumentation available to PCC members and critical for PCC strategic goals.